Role of cytoskeletal interactions with mechanogated ion channel Piezo2 in the mechanism of mechanotransduction by enteroendocrine cells

Project Summary/Abstract
Around 15% of the US population suffers from a motility or functional GI disorder (FGID), like irritable bowel
syndrome (IBS). The pathophysiology of FGIDs remains poorly understood, leading to poorly targeted
treatments. Enteroendocrine cells (EECs) in the GI epithelium release signaling molecules that control many
processes affected in FGID patients, like motility and secretion. A large proportion of FGID patients have
abnormalities in mechanosensation. A population of mechanosensitive EECs in the GI epithelium exhibits
structural and functional similarities with specialized sensory epithelia, such as light touch receptors in the skin.
The mechanosensitive EECs sense physical forces and convert them into hormone release. Thus,
mechanosensitive EECs are primary mechanotransducers in the GI epithelium, and they may be targets for the
treatment of FGIDs. They are characterized by expression of Piezo2, an ion channel that opens in response to
force. Piezo2 generates a receptor current that initiates EEC mechanotransduction. Piezo2 is not the only
mechanosensitive protein in these cells: actin fibers and tight junctions are also critical in epithelial force
transmission. Understanding Piezo2 localization and its functional interactions with other mechanosensitive
proteins is important for understanding sensory epithelial mechanotransduction. The overall goal of this
proposal is to uncover mechanisms by which mechanosensitive proteins work together in EECs to make them
efficient force sensors. The hypothesis is that the actin cytoskeleton plays a critical role in Piezo2+ EEC
mechanotransduction by linking the channel to other mechanosensors and directly changing channel currents.
Aim 1 investigates the assembly of mechanosensory proteins in the EEC by superresolution imaging and co-
immunoprecipitation studies. These experiments explore direct and indirect interactions between the
mechanosensors Piezo2, actin fibers and claudin-4. Aim 2 investigates how these mechanosensors affect
overall EEC mechanotransduction by tracking force-induced calcium transients and electrophysiological
studies of Piezo2. These experiments explore how force is transmitted in epithelial sheets to initiate the
receptor current. The results of this work are poised to bridge knowledge gaps in Piezo2+ EEC
mechanotransduction, as well as inform broader mechanosensing mechanisms in sensory epithelia. The
proposed work will be carried out in a supportive environment that provides cutting edge tools and expert
knowledge towards achieving the specified goal, including collaborations with experts in cytoskeletal
biology,and an imaging core with vast experience in the proposed imaging techniques. The proposal includes a
comprehensive training plan with physician-scientist mentors, by which the PI will gain valuable skills in the
study of molecular mechanotransduction on clinically relevant questions. Along with research activities, the
plan also includes clinical training and shadowing activities to prepare the PI for his transition to the next stage
of training as a future surgeon-scientist.

Public health relevance
Project Narrative Deficiencies in mechanosensation contribute to functional gastrointestinal diseases (FGIDs) like irritable bowel syndrome (IBS), which collectively affect around 15% of US adults, but mechanosensation has not been directly targeted for treatment because of poor mechanistic understanding of how physical forces influence GI function. Our lab discovered mechanosensitive enteroendocrine cells (EECs) in the GI epithelium that release physiologically active hormones in response to force, so in this proposal we seek to uncover the mechanism by which mechanosensitive proteins work together to make EECs efficient force sensors. Acquiring this knowledge may advance our understanding of mechanosensation in sensory epithelia, and pinpoint targets for the treatment of FGIDs.